PHASE I STUDY--HYCAMPTINE GIVEN BY CONTINUOUS IV INFUSION 24 HRS EVERY 3 WEEKS

To determine the maximum tolerable dose, toxicity, evidence of neoplastic activity and pharmakokinetic behavior of hycamptine given by a 24 hr. continuous infusion once every three weeks to patients.